Obstructive sleep apnea and glycemic dysregulation in adults with type 1 diabetes

Most adults with Type 1 Diabetes (T1D) do not achieve optimal glycemic control, and thus have increased
cardiovascular risk. Obstructive sleep apnea (OSA) is a highly common sleep disorder that is strongly linked to
cardiometabolic dysregulation. About 50% of adults with T1D have OSA. Among adults with T1D, those with
OSA have poorer glycemic control and have higher risk of diabetes-related complications. Despite strong
biological plausibility, it is unknown how OSA impacts glycemic control in T1D. Our overall goal is to investigate
the role OSA in glycemic dysregulation in adults with T1D. We hypothesize that OSA exerts negative effects on
glucose regulation in T1D, leading to suboptimal glycemic control and thus increasing cardiovascular risk in
T1D. We further hypothesize that suboptimal glycemic control in adults with T1D occurs in part through OSA-
induced alterations in counterregulatory hormone release and lipid metabolism, subsequently worsening
glycemic control. To test these hypotheses, we propose a rigorous sleep intervention study with a within-
subject, cross-over design in adults with T1D and OSA (n=40) who are using an insulin pump and continuous
glucose monitoring (CGM). Participants will be studied under two 14-day study conditions in randomized order
with a 4-week washout: untreated OSA and treated OSA. We will perform the same assessments in each
study condition. We will apply all-night CPAP intervention under continuous in-lab supervision to achieve
complete resolution of OSA. Thus, we will use CPAP as a tool to eliminate OSA i.e., “turn off” the disease
state. Participants will continue their daily routine activities outside the lab. Sleep will be objectively assessed
during the study. We will determine to what extent OSA contributes to suboptimal glycemic control in adults
with T1D (Aim1). We will compare 14-day CGM profiles (key clinical CGM metrics) between untreated OSA vs.
treated OSA conditions. We will also determine how alterations in counterregulatory hormone release and lipid
metabolism in the setting of OSA account for suboptimal glycemic control in adults with T1D (Aim 2). We will
compare 24-hour blood profiles under controlled in-lab conditions with standardized meals between untreated
OSA vs. treated OSA conditions and determine how specific hormonal (e.g., glucagon, catecholamines) and
metabolic factors contribute to glycemic dysregulation. We will concurrently assess additional biological and
behavioral factors: sleep stages (e.g., slow wave sleep), insulin dose, subjective sleepiness and sleep quality,
and diabetes self-management behaviors. We will also measure resting heart rate and 24-hour ambulatory
blood pressure, and fasting lipids to determine how OSA impacts these intermediate markers of cardiovascular
risk. The proposed work will be the first intervention study to rigorously examine the role of OSA in glycemic
dysregulation in adults with T1D. Our study will combine real-life and in-lab assessments to determine specific
biological and behavioral factors that may contribute to suboptimal glycemic control in adults with T1D and
OSA. The findings may help identify sleep as a novel intervention target to improve T1D management.

Public health relevance
Obstructive sleep apnea is a highly common sleep disorder in type 1 diabetes. Adults with type 1 diabetes and sleep apnea have poorer glycemic control, but the underlying mechanisms are unclear. This research will elucidate biological and behavioral factors that may contribute to suboptimal glycemic control in adults with type 1 diabetes and sleep apnea. The results from this study may lead to novel sleep interventions and improve diabetes management in people with type 1 diabetes.